2010 Signal Transduction By Engineered Extracellular Matrices; Gordon Research Co

DESCRIPTION (provided by applicant): The Gordon Research Conference (GRC) on Signal Transduction By Engineered Extracellular Matrices was established in 2000 and has become the premier meeting at the intersection of engineered materials, cellular adhesion and signaling, tissue engineering, and stem cell biology. The 2010 meeting, to be held June 27 to July 2, 2010, at the University of New England in Biddeford, ME, adds another important dimension - linking stem cell/engineered matrix constructs to developmental models and human clinical therapy. The meeting Chair will be Dr. Chris Chen and the Vice-Chair will be Dr. Karen Hirschi. These investigators provide complimentary expertise in these emerging fields. The main objective of the conference will be to share the newest knowledge from research on: the establishment and regulation of the cellular microenvironment during development and in postnatal tissues;how the cellular microenvironment can be engineered to control cell function;how the fate of cells can be dynamically tracked in vivo;and how such insights can be applied to the development and optimization of human clinical therapies for tissue repair and regeneration. Thus, this meeting necessarily brings together researchers in diverse fields of biology (including stem cell and developmental biology), chemistry, bioimaging and engineering for both the understanding of cellular function and how this can be harnessed for the repair and replacement of tissues lost or damaged due to disease or injury, which serves to encourage cross-disciplinary thinking. Speakers will include well-established leaders in the field as well as young investigators of exceptional promise. In addition to the plenary talks, the meeting includes lively and highly interactive poster sessions. Importantly, 3 poster presenters will be invited to give short oral presentations in every a.m. session, for a total of 12 oral poster presenters. As an important new feature of the 2010 meeting, the main conference will be preceded by a weekend meeting planned by and for pre-doctoral and post-doctoral trainees in this growing interdisciplinary field. This pre-meeting, the Gordon- Kenan Graduate Research Seminar, will provide a forum for these future leaders in the field to present their work in talks and posters, in a collegial and interactive environment that will add outstanding value to their overall GRC experience. Overall, the meeting will provide a platform for the development of long term interdisciplinary interactions, and expose students and young professionals to the latest ideas and opportunities at the confluence of signal transduction, molecular and cellular biology, biomaterials and tissue engineering. 2 PUBLIC HEALTH RELEVANCE: The Gordon Research Conference on Signal Transduction By Engineered Extracellular Matrices is a biennial meeting of the top investigators in the fields of bioengineering and stem cell biology. The 2010 meeting will be held June 27 to July 2, 2010 at the University of New England in Biddeford, Maine. Nine seminar sessions will be held in which leading researchers will present recent data on a variety of topics relevant to the field. In addition to these invited talks, poster sessions will enable attendees to share new experimental findings in a lively and interactive setting. The meeting will include ample time for informal, collegial interactions that are so essential for carrying out science. A pre-conference organized by and for pre-doctoral and post-doctoral trainees will be held preceding the main meeting. This pre-conference will provide an exceptional forum to establish peer group interaction among future leaders of the field, just prior to the main meeting.

Public health relevance
NARRATIVE The Gordon Research Conference on Signal Transduction By Engineered Extracellular Matrices is a biennial meeting of the top investigators in the fields of bioengineering and stem cell biology. The 2010 meeting will be held June 27 to July 2, 2010 at the University of New England in Biddeford, Maine. Nine seminar sessions will be held in which leading researchers will present recent data on a variety of topics relevant to the field. In addition to these invited talks, poster sessions will enable attendees to share new experimental findings in a lively and interactive setting. The meeting will include ample time for informal, collegial interactions that are so essential for carrying out science. A pre-conference organized by and for pre-doctoral and post-doctoral trainees will be held preceding the main meeting. This pre-conference will provide an exceptional forum to establish peer group interaction among future leaders of the field, just prior to the main meeting. 3